University of Virginia - icddr,b Research Unit for Women's and Children's Health Research

Project Summary
We propose that the University of Virginia (UVa) and icddr,b become a Research Unit (RU) within the Global
Network for Women's and Children's Health Research.
Significance: Mothers and children in Bangladesh and other low-mid income countries suffer disproportionately
from maternal and infant malnutrition, neonatal mortality from diarrhea and respiratory infections, vaccine
failure and impaired child development. The UVa-icddrb Research Unit (RU) will address these critical needs
of women and young children by complementing the existing Network strengths with added scientific expertise
in infectious diseases, neurocognitive development, human genetics, maternal-fetal medicine, immunology,
and vaccinology. The RU will also provide extraordinary access to rural and urban populations for clinical trials.
Investigators: The RU Principal Investigator (PI) William Petri and Senior Foreign Investigator (SFI) Rashidul
Haque have for 25 years co-led multidisciplinary teams studying maternal-child, with over 100 co-publications
and eight on-going clinical trials or observational studies. They are joined at icddr,b by a multidisciplinary team
of F. Qadri (Immunology), K. Zaman (Vaccinology), F. Tofail (Child Development), M. Billah and S. El Arifeen
(Maternal and Child Health), T. Ahmed (infant nutrition) and at UVa by C. Chisholm (ob/gyn) and R. Sinkin
(neonatology).
Innovation: The RU has a long history of innovative studies and expertise in maternal-child health, including
the impact of infection and inflammation on child neurocognitive development, role of airborne pollutants on
respiratory infection, function of gut damage in oral vaccine failure and malnutrition.
Approach: The RU will work within the Network to promote innovative studies that have the potential to lead to
actionable and sustainable improvement in maternal and child health through the partnership of the RU with
the government of Bangladesh (manifest through the worldwide implementation of oral rehydration solution,
discovered at icddr,b and adoption nationwide of the Matlab model of community based care).
Environment: The RU has unparalleled multidisciplinary strength, laboratory facilities and access to urban
and rural populations of mothers and children. The icddr,b is one of the foremost global health institutes in
the developing world with over 200 active clinical trials/protocols. The UVa Division of Infectious Diseases
and International Health is the largest research unit at UVa with over $20 million in annual grant support and
over two dozen active clinical protocols. The quarter of a century UVa-icddrb collaboration and unique and
complementary expertise promises to bring unparalleled strengths to the Network's goal of making
sustainable improvements in maternal and child health.

Public health relevance
PROJECT NARRATIVE This proposal is to make the University of Virginia and the icddr,b a Research Unit within the Global Network for Women's and Children's Health Research. The UVa-icddr,b RU would add innovative and complementary expertise in vaccinology, neonatal health, immunology, infection, maternal-fetal medicine and human genetics to the already robust strengths of the Network. The RU will build on the 25 year history of co-leadership of clinical studies by the PI Dr. Petri and SFI Dr. Haque, and the rich history of sustainable improvements in maternal-child health through the icddrb (most notably the invention and implementation of oral rehydration solution), to help achieve the Network goals.